Poly(ADP-ribose) promotes the condensation and toxicity of C9orf72 arginine-rich dipeptide repeat proteins

A GGGGCC hexanucleotide repeat expansion in the C9orf72 gene is the most common genetic cause of
amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD), two devastating neurodegenerative
diseases with no effective treatment. We have shown that transcripts of the expanded repeat undergo an
unconventional mode of translation, resulting in the production of five dipeptide repeat proteins (DPRs). Our
group and others demonstrated that DPRs form neuronal inclusions throughout the central nervous system of
patients with C9orf72-associated ALS and FTD (“c9ALS/FTD”). The identification of this neuropathological
hallmark shed new light on possible disease mechanisms, and our systematic assessment of DPRs in human
tissues, along with their evaluation in mice and other preclinical models, indicate that the arginine-rich DPRs,
poly(GR) and poly(PR), are especially toxic. Our data further suggest that this toxicity stems, at least in part,
from the co-condensation and/or co-aggregation of these DPR proteins with proteins that regulate essential
cellular functions, such as stress granule biology and nucleocytoplasmic transport. We have also shown that
poly(GR) aggregation induces TDP-43 pathology, another hallmark feature of c9ALS/FTD and of the majority
of sporadic ALS and FTD cases. Nevertheless, since poly(GR) and poly(PR) interact with more than 200
endogenous proteins, they are likely to adversely influence a host of cellular functions – a line of investigation
that merits attention. Also of importance is determining the underlying factors that regulate poly(GR) and
poly(PR) condensation and aggregation, and their interactions with other proteins. It is thus notable that our
preliminary data show that poly(ADP-ribose) (PAR) promotes poly(GR) and poly(PR) condensation, and
enhances their co-condensation or co-aggregation with disease-related proteins in vitro. Moreover, we
observed that reducing PAR suppresses poly(GR)- or poly(PR)-mediated neurodegeneration in Drosophila. In
light of these exciting findings, we hypothesize that PAR mediates the aggregation and toxicity of arginine-rich
DPRs and the proteins to which they bind. Thus, the goal of the proposed project is to determine how PAR
does so. To this end, we will identify proteins that interact with poly(GR) or poly(PR) in a PAR-dependent
fashion, and investigate the contribution of PAR to arginine-rich DPR aggregation and toxicity using multiple
preclinical models and brain tissues from C9orf72 expansion carriers. Overall, by availing the diverse expertise
of our team members, we endeavor to elucidate the role of PAR and arginine-rich DPR proteins in c9ALS/FTD
pathogenesis, and thus uncover novel therapeutic targets to expedite the development of effective treatments
for c9ALS/FTD.

Public health relevance
Amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) are devastating neurodegenerative diseases with no effective treatment. Using a combination of elegant model systems and human tissues, our goal is to decipher the molecular underpinnings of the most common genetic form of ALS and FTD – findings that will inform the discovery of new therapeutic targets and treatment development.